Outpatient Mental Health Treatment, Median Household Income, and Residential Segregation: Improving Measurement of Spatial Accessibility for Medicaid Recipients

PROJECT SUMMARY
Medicaid recipients face challenges in accessing mental health services due to low participation by providers.
Outpatient mental health providers are particularly inaccessible to Medicaid recipients compared to privately
insured individuals, and racialized disparities for mental health treatment can also be observed among Medicaid
recipients. Given ongoing challenges in mental health treatment access, particularly among low-income and
racialized individuals, identifying potentially modifiable factors that could increase provider access for these
populations is an urgent priority. One measure of access to health services is spatial accessibility, i.e., the
relationship between the location of providers and potential patients, with consideration to travel distance or time.
Two geographic factors that may contribute to reducing spatial accessibility to Medicaid-accepting mental health
providers are neighborhood-level median household income and residential segregation. Firstly, Medicaid
recipients are becoming increasingly concentrated in low-income neighborhoods due to income-driven
segregation, and lower neighborhood-level median income influences office-based and facility-based provider
density. Secondly, due to a legacy of social and institutionalized forms of residential segregation, racialized and
minoritized Medicaid recipients may be particularly vulnerable to geographic barriers to mental health provider
access. Therefore, spatial analyses of Medicaid mental health workforce shortages require simultaneous
assessment of neighborhood-level income and residential segregation to better serve racialized and minoritized
populations. In this study, Aim 1A will assess whether lower median household income at the census-tract level
is associated with lower spatial accessibility to outpatient Medicaid-accepting providers. Aim 1B will assess
whether lower residential segregation at the census-tract level is associated with lower spatial accessibility to
Medicaid-accepting outpatient mental health providers. If median household income and residential segregation
are individually associated with spatial accessibility of providers, Aim 2 will assess whether residential
segregation at the census-tract level modifies the association between median household income and spatial
accessibility to Medicaid-accepting outpatient mental health providers. For all aims, three categories of outpatient
providers will be assessed: 1) overall 2) office-based 3) outpatient facility-based. Findings from this study will
advance the National Institute of Mental Health’s strategic plan goal to “conduct research to better understand,
predict, and reduce mental health workforce shortages…in certain geographic areas (e.g., underserved
communities).” Accomplishing these aims would also increase our understanding of how to address structural
racism and mental health inequity for Medicaid recipients in the US. The results can inform policies and
programmatic efforts to reduce workforce shortages, such as informing field placements for existing loan
repayment programs in underserved areas. The science presented in this proposal will lay the foundation for the
future career of the Principal Investigator, a Punjabi woman and junior scientist, as an independent researcher.

Public health relevance
PROJECT NARRATIVE This proposal examines two structural factors that may contribute to reduced spatial accessibility to Medicaid- accepting mental health providers: neighborhood-level median household income and residential segregation. The results of this dissertation will directly serve marginalized groups by identifying potentially modifiable factors that could increase provider access for low-income and racialized individuals. Moreover, the developed methods will provide a pragmatic and iterative technique for identifying provider shortage areas and reducing access disparities over time.